Elucidating the Role of MRSA SasF in Skin Colonization and Disease

PROJECT SUMMARY
Staphylococcus aureus and its methicillin-resistant derivative (MRSA) are the top causative agent of skin and
soft tissue infections globally. Though the pathogenic potential of MRSA is unparalleled, approximately 30% of
all humans are asymptomatically colonized with S. aureus, mainly in the anterior nares. This colonization by S.
aureus is directly correlated to an increased infection probability at multiple sites, making colonization an
important step in the S. aureus pathogenic lifestyle. Though S. aureus colonizes a significant portion of the
population, a comprehensive understanding of all the factors used by S. aureus to colonize the skin remain
unknown. This proposal aims at characterizing the hypothetical protein SasF, and its role in skin MRSA skin
colonization and pathogenesis. Previously, our group has performed an RNAseq experiment aimed at assessing
MRSA transcriptomic changes that ensue following colonization of healthy murine skin. In this experiment, we
observed that sasF was significantly upregulated at both 5- and 24-hours post-colonization. In preliminary
studies, we have shown that MRSA SasF is involved in providing MRSA with protection against antimicrobial
lipids that are readily found within the skin barrier. We have also shown that a MRSA mutant lacking the capacity
to produce SasF is greatly hindered in virulence in a skin-abscess infection model. This proposal seeks to
understand how SasF contributes to host skin colonization and infection, and how SasF may mechanistically
protect MRSA against these host skin lipids. I hypothesize that SasF protects MRSA against host antimicrobial
lipids through charge differences in the wall teichoic acids, and that SasF-mediated cell surface charge
modulation provides MRSA with the crucial ability to colonize and infect the skin of a host. These hypotheses
will be tested both biochemically and within the context of a host-environments by a variety of in vitro and in vivo
biochemical and infection-model approaches in these specific aims: Aim 1: Determine the role of SasF in host
colonization and infection and Aim 2: Determine how SasF protects MRSA from skin relevant antimicrobial lipids
via the modification of the cell surface charge. In all, the data generated from this proposal will not only increase
our collective knowledge of the factors required for S. aureus to colonize and infect skin but will also generate
crucial data characterizing how bacteria overcome innate host-lipid defenses. Furthermore, this proposal may
help to reveal SasF as a novel antimicrobial therapeutic target which could be used as a target for not only
preventing S. aureus skin colonization, but also managing clinically relevant and difficult to treat MRSA infections.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus colonizes the approximately 30% of the population persistently, and this colonization is directly correlated to an increased risk of skin and soft tissue infections at all body sites. Though a large proportion of the human population is colonized by S. aureus at any given time, a holistic understanding of how S. aureus colonizes skin, and how this skin colonization leads to infection, remains unknown. This proposal seeks to understand how MRSA uses the novel colonization and virulence factor, SasF, to overcome the antimicrobial lipid defenses of the skin to promote skin colonization and infection.